Development of Advanced Oligonucleotides for Glioblastoma Therapeutics

PROJECT SUMMARY
Glioblastoma multiforme (GBM) is the most frequent and aggressive primary brain tumor in adults. Despite
significant progress being made in characterizing the genetic, epigenetic, and molecular drivers of GBM, effective
therapies remain limited. A considerable hurdle between GBM research and translation into efficacious treatment
is the extensive infiltration and molecular heterogeneity of GBM tumors, both of which cause tumor recurrence
after treatment. Consequently, the average survival expectancy for GBM patients is less than 15 months after
diagnosis. For therapies to be effective in treating these lethal tumors, they must overcome both GBM infiltration
and heterogeneity.
Antisense oligonucleotides (ASOs) – compounds that can modulate the expression of virtually any RNA molecule
– offer distinct advantages for combating GBM infiltration and heterogeneity. Following local delivery, ASOs
distribute throughout the brain, a necessary feat to reach infiltrative GBM cells. Moreover, as sequence-
programmable agents, ASOs possess the specificity and flexibility required to modulate expression of multiple
gene targets – an effective strategy to characterize and combat GBM heterogeneity. In 2016, the ASO drug,
nusinersen, was FDA approved to treat spinal muscular atrophy, establishing the clinical efficacy of ASOs in the
central nervous system. However, several ASO drug candidates for GBM have failed in clinical trials due to high
toxicity and low potency. Identifying potent, well-tolerated ASOs for gene modulation in brain tumors would open
the door to developing effective GBM therapies.
The Watts lab has developed chemically-optimized, non-toxic ASOs with enhanced distribution and potency in
the brain following local CNS delivery. However, their effect on GBM is unknown. The goal of this proposal is
to identify ASOs that potently and safely silence GBM drivers, and assess the impact on tumor progression and
resistance in vivo. With support from Drs. Jonathan Watts (oligonucleotide chemistry), Richard Moser (neuro-
oncology), Sunit Das (GBM mouse models), Manuel Garber (bioinformatics), and Michael Green (cancer biology
& therapeutics), Aim 1 will test the ability of chemically-modified ASOs to silence a clinically-relevant GBM driver
(ATF5), inhibit cell proliferation, and induce cell death in molecularly-distinct patient-derived GBM cell lines. Lead
compounds will then be evaluated for therapeutic efficacy in a GBM mouse model by measuring ATF5 silencing,
tumor growth, and mouse survival following treatment. In Aim 2, the consequences of ASO-mediated silencing
on GBM tumor biology will be investigated. ASOs targeting ATF5 will be injected into GBM tumors of mice. After
treatment response, residual GBM cells will be isolated for single-cell RNA sequencing to characterize the
transcriptome and determine how ASO silencing perturbs functional heterogeneity. This aim will establish a
rational framework for drug combinations to minimize GBM tumor resistance. Collectively, the proposed project
will advance ASOs as a novel GBM therapeutic and as a tool to dissect GBM progression.

Public health relevance
PROJECT NARRATIVE Glioblastoma multiforme (GBM) is a lethal, aggressive brain tumor that resists current standard treatments. This study seeks to identify and use novel nucleic acid drugs to inhibit drivers of GBM tumors, and assess the impact on tumor growth and resistance in a GBM mouse model. This work will reveal key insights into the biology of GBM, and inform the development of effective therapies for GBM and other brain tumors.